Systematic in vitro and in vivo genetic analysis of C.albicans protein kinases

PROJECT SUMMARY
Candida albicans is both a commensal component of the normal human microbial flora and an important
human pathogen. Although the commensal niches occupied by C. albicans are primarily limited to the
gastrointestinal and genitourinary tracts, candidal disease, in contrast, can involve a wide range of organ
systems including kidney, spleen, liver, heart, eye, the central nervous system, and skin/mucosae. As such, C.
albicans is a versatile pathogen that adapts to a wide range of physiologically diverse environments within the
human host. Understanding the systems that facilitate this adaptation is central to developing detailed
mechanistic models of C. albicans pathogenesis and could inform the identification of new therapeutic
approaches to candidiasis. To date, C. albicans transcription factors (TF) are the best characterized
components of this system, due in part to the availability of comprehensive sets of TF deletion mutants. In
contrast, upstream regulators of C. albicans physiology such as protein kinases (PK) have not been
systematically studied to the same extent. To address this knowledge gap, the long-term goal of our project is
to systematically characterize the role of PKs in C. albicans pathobiology. As a first step toward this goal, we
propose to: 1) generate and validate a barcoded set of homozygous and heterozygous C. albicans PK deletion
mutants using a transient CRISPR/Cas9 strategy; 2) Systematically characterize the PK deletion mutants in
two murine model of candidiasis and two virulence relevant in vitro processes: biofilm and hyphae formation; 3)
Identify and characterize the network of PK-TF pairs that regulate biofilm and hyphae formation using genetic
interaction analysis. Successful completion of these aims will provide a useful genetic resource for the
research community, provide the first systematic functional characterization of C. albicans PKs in vivo and in
vitro, and set the stage for subsequent in-depth analyses of the genetic networks regulated by C. albicans PKs.

Public health relevance
PROJECT NARRATIVE Candida albicans is one of the most common human fungal pathogens and affects all people of all ages, causing disease ranging from superficial mucosal irritation to life threatening infections of critical organs. Currently, there are limited therapeutic approaches to candidiasis and understanding the pathways that mediate C. albicans survival in the host and its ability to cause disease is critical to developing new approaches. Protein kinases are among the most prevalent new drugs in development for many diseases. Here, we propose to genetically characterize the set of C. albicans protein kinases as an approach to deepen our understanding of pathogenesis and potentially identify new antifungal drug targets.